Cryopreserved Human Umbilical Cord as a Meningeal Patch in Fetoscopic Spina Bifida Repair (HUC-FICS): Single Arm Phase III Trial

PROJECT SUMMARY
Fetal intervention to repair spina bifida in utero has dramatically improved clinical outcomes for affected children,
but they still face lifelong morbidity characterized by ongoing deficits in motor function. Spinal cord tethering
(SCT) due to scar formation at the surgical site contributes to suboptimal motor outcomes and long-term
neurological complications and may require multiple surgeries in later life. The conventional method for in-utero
spina bifida repair—open hysterotomy with two-layer closure of the neural tube defect—may contribute to SCT,
as it disrupts the arachnoid meningeal layer, a protective barrier that reduces the spinal cord’s exposure to
inflammatory cells and fibroblasts involved in scar formation. In addition, open hysterotomy increases maternal
risks, including risk of uterine rupture, and necessitates cesarean delivery. Novel treatment strategies are needed
to minimize inflammation and scarring at the spina bifida repair site while decreasing maternal morbidities
associated with hysterotomy. To address these needs, we have developed an innovative approach consisting of
laparotomy-assisted fetoscopic (LAF) spina bifida repair using a cryopreserved human umbilical cord graft (HUC)
as a meningeal patch placed between the spinal cord and skin layer. Our preclinical studies demonstrated that
using HUC as a meningeal patch for spina bifida repair improved spinal cord function by reducing inflammation
and SCT and by regenerating the arachnoid layer. Based on these findings, the FDA approved human studies
of spina bifida repair with HUC using a minimally invasive LAF approach. We successfully completed the
feasibility study in 50 patients, more than half of whom delivered vaginally, and the Single-Arm Phase III efficacy
study is underway. This study aims to evaluate neurological, motor functional, and developmental outcomes,
and their correlation with radiological assessments of SCT, in children undergoing LAF spina bifida repair with
HUC patch. We hypothesize that LAF spina bifida repair with a HUC patch will improve 12- and 30-month clinical
outcomes compared with conventional repair outcomes from the randomized Management of Myelomeningocele
Study (MOMS). We will test this hypothesis via three specific aims. Aim 1 will compare neurological outcomes
for children undergoing LAF spina bifida repair using HUC meningeal patch against outcomes after conventional
prenatal repair at 12 and 30 months. Independent ambulation at 30 months is our primary outcome. Aim 2 will
characterize anatomic changes at surgical repair sites using Magnetic Resonance Imaging (MRI) after LAF spina
bifida repair and correlate with functional status. Pediatric neuroradiologists will quantify the tethering index to
assess the degree of SCT. Aim 3 will evaluate standardized developmental outcomes at 30 months in children
after LAF spina bifida repair. In collaboration with a developmental pediatrician, we will assess whether
improvements in motor function translate to developmental improvements for these children. Successfully
achieving these aims will assess LAF with HUC's efficacy and potentially establish it as a viable or superior
treatment for spina bifida repair, improving outcomes for both mothers and children.

Public health relevance
PROJECT NARRATIVE Despite advances in prenatal surgery to repair spina bifida, a congenital defect that affects neural tube development, children still face chronic pain and motor function deficits. Current prenatal surgery approaches create scar tissue that traps the spinal cord, often requiring further surgeries as the child grows, and increase risks to the mother due to large uterine scars. This study will investigate whether using a cryopreserved human umbilical cord patch as a protective barrier over the spinal cord in a minimally invasive procedure reduces scar tissue, improves motor function, and lowers maternal morbidity.